Developing CVD prediction models for women with early stage breast cancer

ABSTRACT
In a Renewal Application of the Pathways Heart Study (R01CA214057), we extend our research by
developing, testing, and validating two cardiovascular disease (CVD) risk prediction models, leveraging
available clinical and “precision cardio-oncology” data in stage I-III breast cancer (BC) patients. BC survivors
are at high risk of developing and dying from CVD following BC diagnosis compared to women without a BC
history due to cardiotoxic BC treatments and shared risk factors between BC and CVD. Clinical risk prediction
tools are needed to identify BC survivors at high risk of serious, life-threatening CVD so that appropriate
surveillance and management can prevent and mitigate sequelae of CVD. Risk prediction tools are commonly
utilized in clinical breast oncology and cardiology, but to date, no established CVD risk prediction tools for BC
patients are available that account for CVD risk factors and BC treatment history. Recently, genomic and
blood-based biomarker data have been shown to substantially increase the predictive ability of risk prediction
models that rely solely on clinically available data. The Pathways Heart Study (R01CA214057) is an
established cohort of 14,942 women diagnosed with stage I-IV BC at Kaiser Permanente Northern California
(KPNC) from 2005-2013 and followed through 2021, which expanded upon the original Pathways Study cohort
of 4,504 BC patients (U01CA195565). In this Renewal Application, we enrich the cohort by adding 25,684+
new stage I-III BC patients and 5 years of follow-up on existing participants, creating a cohort of 40,626+
women diagnosed with stage I-III BC from 2005-2024 and followed through 2026. The expanded cohort adds
contemporary BC treatment exposure data and increases the power to build prediction models with clinical
utility. We leverage existing genetic data from the Pathways Study and cardiometabolic biomarker data from
the Pathways Breast White Adipose Tissue Inflammation study (R01CA241409), collect new data on high-
sensitivity cardiac troponin T (hs-cTnT), extract new CVD risk factors from KPNC clinical records, and utilize
two external validation cohorts. Specific Aims: Aim 1) To develop and evaluate a prediction model to quantify
risk of serious CVD events (heart failure/cardiomyopathy, ischemic heart disease, stroke, clinically significant
arrhythmia, and CVD death) in women with a diagnosis of stage I-III BC using readily available KPNC clinical
data; Aim 2) To develop a “precision cardio-oncology” risk prediction model for serious CVD using data from
women with stage I-III BC in the KPNC Pathways Study with available genotype and biomarker data collected
near the time of diagnosis; and Aim 3) To validate and compare the performance of models developed in Aims
1 and 2 using two external cohorts. If successful, our models will accurately identify early-stage BC patients at
high risk of developing serious life-threatening CVD who need increased surveillance and management. As
warranted, the next steps in our research will be to develop and test an online tool for clinical use, and to
continue to develop and validate the models as new BC treatments become available.

Public health relevance
NARRATIVE Breast cancer survivors are at high risk of cardiovascular disease (CVD) due to cardiotoxic breast cancer treatments and shared risk factors with CVD. In a Renewal Application of the Pathways Heart Study, we leverage existing resources to develop, test, and validate two CVD risk prediction models that will identify early-stage breast cancer patients at high risk of developing serious, life-threatening CVD who need increased surveillance and management. The models will use readily available clinical and biomarker data that are easy to collect with the long-term goal of developing a freely available online CVD risk prediction tool to use in the breast oncology clinical setting.